1/2: CO2 Reactivity as a Biomarker of Non-response to Exposure-based Therapy

PROJECT SUMMARY/ABSTRACT
Exposure-based therapy is an effective first-line treatment for anxiety-, obsessive-compulsive and trauma-
and stressor-related disorders. 1–6 However, many patients fail to respond or achieve remission with exposure-
based therapy, 7–11 resulting in “unnecessary” prolonged suffering, loss of productivity, and poorly used
resources. Making available a biomarker assay that can aid clinicians and patients in treatment selection has
the potential to have considerable public health impact.
Basic research on fear extinction - a core mechanism of action of exposure-based therapy - may inform
the development of a biomarker for the selection (yes/no) of exposure-based therapy. Growing evidence links
12,13
14–16
orexin system activity to deficits in fear extinction.17–20 Our group has demonstrated that reactivity to CO2
challenge, which is a safe, affordable and easy-to-implement procedure, can serve as a proxy for orexin
system activity and predicts fear extinction deficits in rodents.21
Building upon this basic research, the goal for the propo
sed study is to validate CO2 reactivity as a
biomarker of exposure-based therapy non-response.
To this end, we will assess
CO2 reactivity in
600 adults
meeting for one or more fear- or anxiety-related disorders prior to providing open, state-of-the art,
transdiagnostic exposure-based therapy. By incorporating CO2 reactivity into a multivariate model predicting
treatment non-response that also includes reactivity to hyperventilation as well as a number of related and
theoretically-relevant prognostic variables, we will establish the mechanistic specificity and the additive
predictive value of the putative biomarker. By developing models independently within two study sites and
predicting the other site's data, we will validate that the results are likely to generalize to future clinical
samples.
The proposed study represents a necessary stage in translating basic research to strategies for treatment
selection. The investigation addresses an important public health issue by testing an accessible clinical
assessment strategy - informed by basic research - that may lead to a more effective treatment selection
(personalized medicine) for patients with anxiety- and fear-related disorders and enhance our understanding of
the mechanisms governing exposure-based therapy.

Public health relevance
PROJECT NARRATIVE Anxiety-, obsessive-compulsive and trauma- and stressor-related disorders reflect a significant public health problem. This study is designed to evaluate the predictive power of a novel biomarker based on a CO2 challenge, thus addressing the central question “can this easy-to-administer assay aid clinicians in deciding whether or not to initiate exposure-based therapy?”